Low Cost, Fully Implantable Wireless Neural Recording Device

Project Summary/Abstract
The proposed project will develop a device that records brain and muscle signals (electroencephalography and
electromyography, EEG/EMG) from behaving rodents without the cumbersome, expensive, and maintenance-
intensive wires or batteries that hinder the usefulness of existing commercially available systems. By delivering
both power and data wirelessly, and entirely eliminating all external implants on the animal, our technology will
extend brain recording capabilities to sensitive behaviors, such as sleep-wake behavior or social interaction, that
are easily disrupted by external tethers, and will enable long-term recordings and recordings from animals
behaving in three-dimensional naturalistic environments, that are impossible with current technology.
Furthermore, the system we will develop is fully compatible with existing NeuroLux HF wireless electronic
platform and control software, allowing us to leverage the strengths of an existing commercial platform to further
advance neuroscience research capabilities.

Public health relevance
Project Narrative The proposed program focuses on the development of a batter-free, fully-implantable, device that permits wireless electroencephalography (EEG), with combined, independent functionalities in electromyography (EMG) and temperature sensing. This system is fully compatible with the NeuroLux HF wireless electronic platform. This novel technology represents an important advance in tools for neuroscience research that enable untethered, non-invasive operations in home cages, in simple or complex environments, as individuals or in socially interacting groups.